NBER Center for Aging and Health Research-McGarry Suppl--ADRD/LTC

OTHER PROJECT INFORMATION – Project Summary/Abstract
Alzheimer's Disease and Approaches to Long-Term care in the United States and Around the World
Countries vary widely in how they approach long-term care for people with Alzheimer’s Disease and related
dementias, particularly in the use of public programs and in the type of care provided. This project supports a
developmental first phase of work by an international research network analyzing these cross-national
differences in ADRD care, including comparative analyses of care needs, long-term care policy characteristics
and incentives, financing mechanisms, formal and informal care provided, living arrangements, costs of care,
and outcomes for both caregivers and care recipients. A key goal is to explore potential relationships between
policy characteristics, their implicit incentives, and the observed variations across countries in how they approach
long-term care delivery. The network would be a component project of the NBER Center for Aging and Health
Research, a primary aim of which is to establish and incubate new research networks on important issues relating
to health at older ages. By conducting parallel investigations in each of ten countries, then comparing findings
across countries, the project will take advantage of the rich cross-national variation in long-term care systems to
inform discussions of long-term care delivery in the United States. The aims include constructing measures that
characterize long-term care policy, financing, approach, costs, and outcomes; comparing the long-term care
landscape across countries; exploring relationships between policy, approach, and other outcomes; building a
shared data repository of macro-level international data on formal and informal caregiving; and developing a
multi-year research plan on Alzheimer’s Disease and approaches to long-term care that builds on the phase 1
findings.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The growing prevalence of Alzheimer's Disease and related dementias as the population ages, and the need to care for people living with dementia present serious societal challenges, compounded by the experience of the COVID-19 pandemic. This project analyzes cross-national differences and relationships between long-term care needs, policy characteristics and incentives, financing mechanisms, formal and informal care, living arrangements, costs of care, and outcomes for both caregivers and care recipients.